Developing purinergic receptor inverse agonists for treating triple negative breast cancer

Summary
We propose to develop novel adenosine receptor inverse agonists for the treatment of metastatic triple negative
breast cancer (TNBC). An estimated 280,000 cases of breast cancer are diagnosed annually and 15–20% of
these are TNBC. TNBC often affects younger patients (<40 years old) and disproportionately affects Black and
Hispanic women. TNBC has a poor prognosis, rapidly progressing to distant metastases and developing
resistance to chemotherapy. Because TNBC is negative for hormone receptors (HR-) and human epidermal
growth factor receptor 2 (HER2-) biomarkers, current HR- and HER2-directed therapies are ineffective. In
addition, most do not have identified markers (e.g., BRCA, PD-L1), precluding the use of other targeted
therapies. As a result, conventional chemotherapy—which has poor tolerability and drug-resistance issues—is
the standard of care for most late-stage TNBC patients. Overall, TNBC has a high rate of recurrence/metastasis,
low survival rate, high treatment costs, and no cure. Thus, there is a critical need for novel treatments for late-
stage TNBC. We have identified inhibition of the A2 purinergic receptors (A2R), A2AR and A2BR, as a promising
strategy for overcoming the barriers of conventional TNBC therapies, including toxicity and drug resistance.
Purinergic signaling is activated when adenosine binds to A2AR and A2BR, promoting cancer growth and
suppressing anti-tumor immunity. We have identified several novel A2R inverse agonists with a unique
mechanism of action (MOA), not only inhibiting adenosine-induced signaling, as do neutral antagonists, but also
reducing basal-level signaling, resulting in more potent inhibition than neutral antagonists. Both in vitro and in
vivo studies show that these compounds are orally bioavailable and effective inhibitors of tumor growth,
migration, and metastasis in TNBC, while having no identified toxicities. While our current A2R inverse agonists
exhibit strong efficacies, tolerability, and many favorable drug characteristics, they do have limitations, including
low solubility, limited oral bioavailability, short half-life, and less than optimal stability in blood. In this application,
we plan to address these limitations by optimizing these compounds through computer-aided and AI-based drug
discovery technology including structure-based de novo design and large-scale analog screening, as well as
further medicinal chemistry optimization by undertaking three specific aims: 1) Design and generate optimized
A2R inverse agonists and evaluate potential improvements in drug properties, target affinity, efficacies, and anti-
tumor immunity, 2) Perform PK analysis to select compounds with improved stability, oral bioavailability, and
high levels of tumor tissue distribution and efficacy, 3) Evaluate dose-dependent efficacy and immune system
effects in multiple mouse models. Success will identify and establish the resulting optimized drug candidate
compound(s) as pioneering A2R dual inverse agonists, designed to treat TNBC, as well as a variety of
immunogenic cancers. Our drug candidate with a novel MOA has the potential to benefit TNBC patients by
improving their overall survival, particularly those ineligible for or resistant to current therapies.

Public health relevance
Narrative An estimated 280,000 cases of breast cancer are diagnosed annually and 15–20% of these are triple negative breast cancer (TNBC), an aggressive form that is negative for hormone receptors (HR-) and human epidermal growth factor receptor 2 (HER2-) biomarkers, making current HR- and HER2-directed therapies ineffective. TNBC has a poor prognosis, rapidly progressing to distant metastases and developing resistance to chemotherapy, with a high rate of recurrence/metastasis, low survival rate, high treatment costs, and no cure. This project will advance development of the novel adenosine receptor inverse agonist inhibitors to overcome the barriers of conventional TNBC therapies, including toxicity and drug resistance, in order to treat metastatic TNBC and improve the overall survival of TNBC patients.